Enhancing capacity in faith-based organizations to implement and sustain multilevel innovations to improve physical activity

PROJECT SUMMARY
Despite the benefits of physical activity (PA) to prevent cardiovascular disease (CVD) and other chronic
diseases, few adult Latinas meet PA guidelines. Given the central role of faith-based organizations (FBOs)
within the Latino community and their commitment to the well-being of their members, FBOs are ideal settings
for health promotion. Evidence-based approaches for increasing PA and reducing obesity such as Faith in
Action exist, but few PA interventions go to scale. Implementation strategies that enhance the capacity of FBO
leaders and community health workers (promotoras) to implement EBIs can facilitate their uptake. We propose
to enhance Faith in Action with three organization-level strategies designed to increase program fit and
effectiveness: 1) training FBO leaders in health promotion 2) tailoring messaging to enhance fit between Faith
in Action and each unique FBO context, and 3) empowering promotoras to advocate for organizational change.
Given the need to improve strategies to sustain health programs in community settings, we propose to test the
influence of two additional sustainment strategies: 1) strengthening community collaborations and 2) providing
technical support. We will conduct a hybrid type II effectiveness-implementation trial using a clustered RCT
design to test the impact of the proposed implementation strategies on organization-level change and
individual behavior in diverse FBOs for a 12-month intervention and 6-month follow-up. Thirty-two FBOs will be
randomly assigned to a Standard EBI condition (Faith in Action as originally implemented), an Enhanced
condition (Standard condition + organizational-level implementation strategies), or Enhanced + Sustainment
condition (Enhanced implementation condition + sustainment strategies). We will collect quantitative and
qualitative data at baseline, 6 months, 12 months, and 18 months post baseline. The proposed study aims to:
1) Test the short and long-term impacts of organization-level implementation strategies in 2 Enhanced
conditions on organizational outcomes compared to the Standard EBI condition, 2) Examine individual reach
and effectiveness among Latinas (n=812) in FBOs in the 2 Enhanced conditions compared to the Standard
EBI condition. Secondary aims examine theoretical mechanisms of action (e.g., organizational climate) and the
additional impact of two sustainment strategies. Informed by the Practical Robust Implementation and
Sustainability Model (PRISM) and Reach Effectiveness-Adoption Implementation and Maintenance (RE-AIM)
frameworks, the current study will use mixed methods to adapt Faith in Action to diverse FBOs. This research
is innovative because it experimentally tests organization-level implementation strategies and their associated
mechanism of action in Latino FBOs' from diverse denominations. Our findings will impact the field by
providing rigorously derived evidence for the scale-up of innovative EBIs in FBOs. If successful, findings from
the current study will provide evidence of organizational-level strategies for uptake, sustainment, and
generalizable implementation strategies for scale-up of PA interventions to increase PA and reduce chronic
disease in FBOs across the US.

Public health relevance
PROJECT NARRATIVE Physical Despite aims evidence-based based inactivity is prevalent and chronic diseases impact racial/ethnic minorities at a disproportionate rate. the availability of evidence-based physical activity interventions, few go to scale. The proposed study to develop and test implementation strategies to accelerate the uptake, spread, and sustainment of an physical activity intervention to improve health outcomes of underserved communities in faith- organizations.